Cryo-TEM for Biomedical Research

Summary
Brown University requests support for a Tundra Cryo-Transmission Electron Microscope (Cryo-TEM). This
microscope will be used to examine protein structure by single particle analysis for a better basic understanding
of biochemical processes in health and disease. Vitrified samples imaged on the Tundra Cryo-TEM can be
recovered for cryo-electron microscopy (cryo-EM) at high resolution in national cryo-EM centers. In addition, the
requested microscope will be used as a standard TEM for imaging small vesicles, organelles and neural
connections in ultrathin tissue sections. The Tundra Cryo-TEM will replace a 39-year-old TEM in the Division of
Biology and Medicine and will be the first Cryo-TEM capable of single particle analysis in the State of Rhode
Island. The Cryo-TEM will be used immediately by 16 investigators. Collectively, these 16 user groups are funded
by 31 NIH grants, covering a broad area in biomedical research ranging from antibiotic resistance and infertility
to aging and neurodegenerative disease. All major users have a substantial need for cryo-EM. These major
users either traveled out of state for cryo-EM or used other technologies that left questions unanswered,
especially when studying large dynamic proteins. The minor users plan to use the requested microscope as a
standard TEM or have cryo-EM projects that were put on hold since the required equipment has not been
available at Brown University. All major and minor users have research projects that would immediately benefit
from the proposed equipment. The impact of the proposed imaging system will extend beyond the projects of
the major and minor users, since the microscope will be made be made available to the broader scientific
community in Rhode Island, which has over 700 active NIH-funded projects. The microscope will be set up in
the Leduc Bioimaging Facility, which has the technical expertise to maintain the instrument and train its users.
In addition, biochemical sample optimization and evaluation will be supported by Brown University’s Structural
Biology Facility and data storage and analysis will be supported by the Center for Computation and Visualization.
The Leduc Bioimaging Facility has a broadly-based Advisory Committee, an excellent track record maintaining
various high-end imaging systems, and strong institutional support, which guarantees that the instrumentation
will be used to its maximum potential for years to come.

Public health relevance
Narrative Brown University requests support for a Cryo-Transmission Electron Microscope (Cryo-TEM), the first system in Rhode Island capable of imaging protein structure by single particle analysis. The Cryo-TEM will be used immediately by 16 laboratories in various areas of biomedical research, ranging from antibiotic resistance and infertility to aging and neurodegenerative disease. The equipment will be placed in a core facility and will be made available to the broader scientific community in the State of Rhode Island.